NEURAL TISSUE MICROCHIP INTERFACE

Development of a neural prosthesis requires fabrication of a solid state device capable of recording information from neural tissue and stimulating it in a timely manner. We began this process by designing a simpler system to test and monitor cultured neural tissue. We identified some problems (such as suitable insulation for the device and corrosion in a critical part of the system) and we improved the tissue culture system to make the tests as realistic as possible. We have also worked with cultured retinal tissue in the system so that two-way communication could be achieved.